Project 3: Development of Strategies to Deplete Myelofibrosis Stem Cells

PROJECT 3 ABSTRACT
PI: Ronald Hoffman, MD
First generation JAK2 inhibitor therapy is currently widely employed to treat myelofibrosis (MF) patients. Its use,
however, has not substantially altered the risk for disease progression or interrupted the inevitable evolution to
MPN-blast phase (MPN-BP), likely due to an inability to selectively deplete MF stem/progenitor cells (HSPC).
MF HSPCs are characterized by upregulation of HDM2 which promotes the proteosomal degradation of wild-
type (WT) p53. We have focused on implementing strategies that upregulate WT p53 activity in order to deplete
MF HSPCs. We subsequently have shown that treatment with the HDM2 antagonist, nutlin-3 antagonizes the
interaction between WT p53 and HDM2 resulting in the upregulation of p53 and the depletion of MF but not
normal HSCs. Furthermore, p53 dependent signaling is known to play a role in tumor suppression by acting in a
non-cell autonomous manner, such that down regulation of p53 leads to upregulation of NFκB resulting in the
increased elaboration of abundant amounts of pro-inflammatory cytokines. Subsequent trials of nutlin therapy in
MPN patients have resulted in an improvement not only in clinical parameters and symptom scores but also
rapid reductions in the variant allele frequencies of MPN driver mutations and other associated myeloid gene
mutations, as well as the reversal of marrow fibrosis. We hypothesize that HDM2 antagonist therapy actually
depletes MF HSPCs and downregulates NFκB in MF cells and components of the tumor microenvironment. The
long-term administration of HDM2 antagonists has, however, proven problematic due to gastrointestinal toxicity.
MPN p53 activity can also be downregulated by activating mutations or overexpression of PPM1D, a
phosphatase which dephosphorylates p53. To further optimize the therapeutic upregulation of WT p53 and
possibly lessen the gastrointestinal toxicity associated with HDM2 antagonist therapy, we hypothesize that
adding drugs that either reduce PPMID activity or antagonize the action of BET proteins (epigenetic regulators
which downregulate events downstream of p53) will result in further upregulation of p53 activity, greater depletion
of MF HSPCs and additional correction of the MF tumor microenvironment. Since HDM2 can also be recruited
to chromatin in a p53 independent manner to increase NFκB, HIF1α, and polycomb repressor complex 2 activity,
as well as orchestrate the global metabolic reprogramming of cancer cells, we hypothesize that agents that
effectively eliminate both the p53 dependent and independent consequences of increased HDM2 copy number,
might result in even greater depletion of MF HSPCs. To test these hypotheses, we will pursue the following
Specific Aims (1) Determine the degree of malignant MF HSCs depletion achieved by up-regulating WT p53
activity with single agent HDM2 antagonist treatment; (2) Determine if dual targeting of HDM2 and PPM1D or
HDM2 and BRD4 leads to further upregulation of p53 activity and a greater degree of MF HSC depletion than
targeting HDM2 alone; and (3) Evaluate if targeting the p53 independent roles, in addition to the p53 dependent
roles, of HDM2 leads to further depletion of MF HSCs.

Public health relevance
Project Narrative Myelofibrosis (MF) is a chronic myeloproliferative neoplasm (MNP), which is primarily the consequence of intrinsic abnormalities occurring within hematopoietic stem and progenitor cells (HSPCs) associated with at least five events: 1) acquisition of MPN driver mutations leading to increased JAK/STAT signaling; 2) increased activation of NF-κB; 3) progressive downregulation of the tumor suppressor p53; 4) upregulation of components of the anti-apoptotic pathways and 5) upregulation of HIF1. These intrinsic MF HSPC abnormalities also lead to additional extrinsic events resulting in a chronic pro-inflammatory state and a dysregulated hematopoietic tumor microenvironment which favors the predominance of malignant HSPCs with increasing burdens of mutational and cytogenetic events. To test this hypothesis, combinations of drugs that upregulate p53 will be evaluated for their potential to disrupt the p53/NF-κB/HIF1 axis, deplete myelofibrosis HSPCs as well as disarm their supportive TME prior to their subsequent evaluation in clinical trials.